Spatial Hearing and Functional Auditory Skills in Children with Unilateral Hearing Loss

PROJECT SUMMARY Children with unilateral hearing loss (UHL) are at an increased risk for a range of developmental difficulties and delays, but there is substantial variability in outcomes for individual children. The factors responsible for these individual differences remain unknown. As a result, there is no consensus regarding the audiologic management of pediatric UHL, which contributes to a costly, failure-­based model of intervention for affected children. The goal of the proposed research is to determine the factors responsible for the difficulties many children with UHL experience in their everyday lives, thus informing clinical assessment and management of UHL. The central hypothesis is that reduced spatial hearing skills in children with UHL are responsible for the deficits observed in this population. The central hypothesis will be objectively tested by pursuing the following specific aims: (1) evaluate spatial release from masking (SRM) in children with mild to severe-­profound sensorineural UHL in a complex speech masker, (2) assess localization on the azimuthal plane in children with UHL, and (3) determine the association between SRM and functional listening abilities for children with UHL. This research project incorporates psychoacoustic techniques and functional listening measurements into the assessment of children with UHL. The expected outcome of this project is a better understanding of how UHL affects SRM and the contributions of interaural difference cues to sound source localization in children with UHL. This outcome is expected to have an important positive impact on clinical practice by providing objective data to guide timely and appropriate audiologic management of children with UHL. The proposed research training program is designed to foster acquisition of the technical skills and background knowledge in binaural hearing, psychoacoustics, and speech perception that are necessary for an independent research career improving outcomes for children with hearing loss, particularly those with UHL.

Public health relevance
PROJECT NARRATIVE The proposed research will evaluate the effects of unilateral hearing loss on children’s ability to benefit from target- masker spatial separation for speech- on- speech recognition, as well as their ability to localize sound sources in space. The association between these abilities and functional, everyday listening skills will be evaluated. Results will have implications for the clinical assessment and treatment of pediatric unilateral hearing loss.